SPORE in Gastrointestinal Cancer

DESCRIPTION (provided by applicant): This application for continuation of the Specialized Program of Research Excellence (SPORE) in Gastrointestinal Cancer at the Sidney Kimmel Comprehensive Cancer Center at Johns Hopkins supports a highly interactive, multidisciplinary, and inter-institutional program. Five research projects within three research themes, four cores, a career development and a research developmental program are proposed to extend our translational research In colorectal and pancreatic cancer. Theme 1: Epidemiology and Inborn risk (Project 1, Markers for risk in familial pancreatic cancer, Drs. Klein, Hruban, and Goggins) Theme 2: Management of risk (Project 2, Markers for screening and diagnosis, Drs. Goggins and Kinzler; Project 3, Diagnostic strategies and risk-assessment for pancreatic cysts, Drs. Kinzler, Maitra, and Goggins). Theme 3: Post-diagnostic management (Project 4, Tumor antigens for individual signatures and therapy, Drs. Jaffee, Kern, and lacobuzio-Donahue; Project 5, Access of therapeutic agents to cancer cells, Drs. Zhou, Kern, and lacobuzio-Donahue). The cores support the research programs (Core 1, Administration and Communication, Dr. Scott Kern; Core 2, Human Tissue Research and Logistics, Dr. Christine lacobuzio-Donahue; Core 3, Familial Cancer Registries, Dr. Frank Giardiello; Core 4, Statistics/Bioinformatics, Drs. Alison Klein. The Career Development Program (Dr. Scott Kern) aids the emergence of new investigators and the Research Developmental Program (Dr. Bert Vogelstein) provides rapid funding of innovative directions.

Public health relevance
Public Health Relevance: This research program provides a spectrum of capabilities, allowing broad research moving from the lab bench to the patient for improved diagnosis and care, and studies of gastrointestinal cancers that move back to the lab for fundamental understanding of their scientific basis.